Quantitative multimodal retinal imaging

Project Summary-Abstract
Our ultimate goal is to develop a multimodal VIS-OCT platform for retinal imaging to improve patient care and to
advance clinical research. We proposed to develop a visible-light optical coherence tomography (VIS-OCT)
platform for multimodal multifunctional imaging of the retina. Two novel VIS-OCT based imaging technologies
will be built in this platform: quantitative fundus autofluorescence (FAF) or VIS-OCT-FAF, and retinal nerve fiber
layer (RNFL) spectral contrast OCT or DUAL-OCT-RNFL. The two new technologies will add new tools for
ophthalmologists to make early diagnosis and better monitor retinal diseases. The proposed work is based on
hypotheses that are strongly supported by our theoretical modeling and solid preliminary data. We hypothesize
that 1) Quantification of absolute FAF intensity can be achieved by normalizing raw FAF signals with an
internal reference and an external standard fluorescence reference; 2) RPE OCT signals
simultaneously acquired with FAF can serve as an internal reference; and 3) The spectral contrast of
the RNFL can be used as a biomarker for RNFL damage by elevated IOP. Three Specific Aims are
proposed. Aim 1: To develop a VIS-OCT platform for VIS-OCT-FAF and DUAL-OCT-RNFL imaging. We will
develop and refine the VIS-OCT platform consisting of a VIS-OCT centered at 480 nm, a NIR-OCT centered at
840 nm, and a FAF detection module. A reference target with known fluorescence efficiency and reflectance
placed in the intermediate retinal imaging plane will serve as a reference to normalize raw data to obtain absolute
FAF intensity and quantitative RNFL spectral reflectance. The reference target will use a PMMA slide stained
with A2E as fluorescent molecule. We will introduce the A2E equivalent unit (AEU) as a measure of FAF. Aim 2:
To study VIS-OCT-FAF and DUAL-OCT-RNFL imaging in phantom and animals. We will test the system in
phantom and animals to verify the capabilities of the VIS-OCT platform, to calibrate and obtain feedback for
fine-tuning the hardware and algorithms. Phantom studies will use a model eye with A2E, melanosome and TiO2
to simulate lipofuscin, absorption and scattering in RPE. FAF images from albino and pigmented rats of different
ages will be studied. A2E in each imaged eye will be quantified by mass-spectroscopy to verify the accuracy of
FAF signals. Elevated IOP will be induced on rats by photocoagulation to the trabecular meshwork. RNFL
spectral contrast images from eyes with or without increased IOP will be compared. Aim 3: To study
VIS-OCT-FAF and DUAL-OCT-RNFL imaging in human subjects. Our ultimate goal is to develop a
multimodal VIS-OCT platform for retinal imaging to improve patient care and to advance clinical research.
Studies in this Aim will allow us to learn how the systems behave in a real clinical setting. We will image normal
subjects of 6 age groups to establish age-based normative data. Patients with early dry AMD and Stargardt’s
disease will also be studied. In the RNFL imaging studies, we will image 6 age groups of normal individuals to
establish age-based normative data. Patients with early stage glaucoma will be studied.

Public health relevance
Project narrative We propose new multimodal imaging technologies based on a visible-light optical coherence tomography (VIS- OCT) platform to quantitatively image the fundus autofluorescence emitted by lipofuscin in the retinal pigment epithelium, and the spectral reflectance of the retinal nerve fiber layer. These novel imaging technologies will add a significant clinical tool for diagnosis, staging, and follow-up of retinal degenerative disorders and glaucoma, and will have a great impact on patient care and clinical trials for potential treatments.